Beyond Binding: Personalized Multi-omic Neoantigen Identification

PROJECT SUMMARY
This project addresses technological challenges in personalized neoantigen immunotherapy for cancer
treatment, focusing on developing a more precise and broadly applicable neoantigen prediction algorithm by
integrating multiomic data. The research aims to innovate in algorithm and software development, enhancing
the selection and validation of neoantigens for immunotherapy.
Despite the potential of personalized neoantigen therapies in oncology, their clinical adoption is hindered by the
time-consuming and costly process of neoantigen selection and validation. Current computational tools for
neoantigen prediction have limited effectiveness due to several factors, including inadequate training on
immunologically validated neoantigens, a bias toward European HLA alleles, and the absence of multiomic
patient data in algorithm training.
Our project leverages a multidisciplinary team and a rich dataset of matched tumor and normal specimens from
diverse patient populations, focusing on underrepresented HLA alleles, and the highly sensitive Mutation-
Associated Neoantigen Functional Expansion of Specific T Cells (MANAFEST) assay for T cell activation and
expansion. We propose to generate the first public dataset of immunologically assessed neoantigens with
patient-matched multiomic sequence data, enhancing the precision of neoantigen prediction through advanced
algorithmic methods and the integration of comprehensive biological data.
The research design includes the creation of a Multiomic Neoantigen Algorithm Training and Assessment
Resource and the development of a novel deep learning-based neoantigen prediction algorithm that utilizes
patient-specific multiomic data. This approach aims to improve the prediction and clinical utility of neoantigen-
based therapies and to provide community resources through open data and open-source software, promoting
wider application and innovation in the field.
By addressing these challenges, the project expects to substantially enhance the precision and applicability of
neoantigen prediction tools, paving the way for their effective use in clinical settings and improving outcomes in
cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE This project aims to improve cancer treatment by developing laboratory tests and advanced software that can accurately predict which cancer-specific markers, known as neoantigens, are likely to activate the immune system. By integrating detailed genetic information from cancer patients, especially those from diverse backgrounds, the technology will help customize immunotherapy treatments to be more effective and accessible. This research could lead to better, more personalized therapies that target cancer cells without harming normal cells, potentially improving survival and quality of life for cancer patients.